Preconception iAs exposure: diabetes and epigenetic inheritance

ABSTRACT: PROJECT 2
Chronic exposure to inorganic arsenic (iAs) has been linked to type 2 diabetes (T2D) in epidemiologic studies.
Yet, critical windows of iAs exposure leading to the development of T2D have not been identified. The association
between iAs exposure and T2D has been reported in populations exposed to iAs for generations. Thus, iAs
exposure of parents prior to conception may contribute to development of T2D in the progeny. Our studies
showed that iAs exposure of both parents prior to conception produces diabetic phenotypes in offspring of wild-
type (WT) mice. However, WT mice metabolize (i.e., detoxify) iAs more efficiently than humans. Project 2 will
use unique genetically diverse humanized mice that express the human AS3MT, the key enzyme in the pathway
for detoxification of iAs. These mice demonstrate a human-like pattern of iAs metabolism, and are more sensitive
to iAs toxicity than WT mice. We hypothesize that preconception iAs exposure causes heritable changes
in the epigenome in parental germ cells, resulting in sex-specific diabetic phenotypes in F1 and F2
offspring, and that the extent and character of these effects depend on genetic makeup of the humanized
mice and dietary intake of methyl group donors, folate, and vitamin B12. We will characterize diabetogenic
effects of parent-specific preconception iAs exposure in F1 and F2 male and female offspring of humanized mice
from Collaborative Cross (CC) that metabolize iAs with different efficiency (Aim 1), determine the role of the
epigenome as a driver of these effects (Aim 2), and establish if supplementation with folate and vitamin B12
protects against these effects by either stimulating iAs detoxification in parental generation or preventing iAs-
induced differential gene methylation in parental germ cells (Aim 3). An alternative hypothesis will also be tested,
which links the diabetic phenotype in the offspring to heritable iAs-induced changes in the gut microbiome of the
parents. The diabetogenic effects of maternal and paternal preconception exposures will be examined
independently using environmentally relevant exposures to iAs in drinking water. The innovative experimental
design will provide direct evidence that DNA methylation and gene expression changes induced by
preconception iAs exposure are restricted to the chromosome inherited from the exposed parent. Using the
humanized CC mouse strains will facilitate translation of mouse data to human populations. This project is led
by a strong team with complimentary expertise in (epi)genetics, molecular biology, iAs toxicology and
metabolism, iAs-induced T2D and statistics. The project is aligned with the theme of the UNC-SRP “Protecting
vulnerable populations from iAs-induced metabolic dysfunction with a vision for exposure reduction and
disease prevention.” Answering questions about which parent drives the effects of preconception iAs exposure
and how efficiency of iAs metabolism influences the outcomes will have a significant public health impact,
providing scientific basis for interventions and treatments to reduce risk of iAs-associated disease.

Public health relevance
NARRATIVE: PROJECT 2 The research in Project 2 is relevant to public health protection and the NIEHS Superfund Program as it will study the role of preconception exposure to inorganic arsenic (iAs) in development of diabetes in two generations of offspring. This project will also identify the molecular mechanisms underlying the diabetogenic effects of this exposure and will explore dietary intervention that has a potential to protect against these effects. The proposed research will use unique genetically diverse humanized mice that exhibit human-like pattern of iAs metabolism, which will facilitate translation of data from mice to human populations.